NON-STEROIDAL MALE CONTRACEPTIVE AGENTS

The objectives of this project are to develop new orally active nonsteroidal agents for control of fertility in the male. It is proposed to synthesize and test a series of new indinopyridine analogs based on the lead compound, Sandoz 20-438 in order to develop a structure activity relationship directed toward enhancing the anti-spermatogenic activity and eliminating untoward pharmacological activities.